2022-2024 US DOHaD Society Meetings

ABSTRACT
The fundamental concept of Developmental Origins of Health and Diseases (DOHaD), which posits that early-
life events or exposures determine the health outcomes across the life span, has been well represented by the
US DOHaD Society exemplified by its annual national meeting since its inception in 2016. Its annual meeting
brings together investigators with diverse backgrounds who otherwise may not likely interact, including those
researching in the areas of developmental biology, life course epidemiology, nutrition, environmental toxicology,
cancer, stress, and endocrinology. Such individuals span institutions across the US from universities to industry
to government agencies (NIH, EPA, NIEHS) to share knowledge and recent advancements on how
environmental toxicants, nutrients, pharmaceutical agents, pathogens, gut microbiota, stress, and emerging
factors influence developing fetuses and newborns, and thereby contribute to their health and disease across
the life span. Further, presentations also delve into how such factors might lead to harmful effects in the
subsequent generations, i.e., transgenerational effects. The major goal of the US DOHaD Society’s annual
meeting is to foster multidisciplinary interactions and promote collaborations on these diverse topics. The second
objective is to provide opportunity for trainees (graduate students, postdoctoral fellows, and junior faculty) to
interact with world-renown experts, facilitating the development of future scientists and career opportunities in
the field. The third objective is to continue promoting diversity, inclusivity, and equal representation of sex, gender
and underrepresented minority groups as speakers and session leaders. Notably, women and minority
represented >50% and >20% speakers and moderators, respectively, over the last five meetings. The past five
conferences have been enormously successful, particularly the 2021 hybrid (in-person and virtual) meeting
despite the ongoing COVID pandemic. Such successes provide impetus for continued and permanent annual
meetings. The 6th, 7th, and 8th Annual Meetings will again be a hybrid format and held at the University of
Minnesota (Minneapolis, 2022), the Mercy’s Children Hospital (Kansas City, 2023) and the Rizzo Center (Chapel
Hill, 2024), respectively. The theme for the 2022 meeting will be “Environmental Exposures: Assessment
Methodologies, Mechanisms, and Health Outcomes”. Analogous to the 2021 meeting, the program will include
a dedicated day on career development and grant writing that will be provided in kind to all trainees. Preliminary
themes for 2023 and 2024 will cover topics including maternal microbiota and child development, exosomes as
carriers of biomarkers, effects of maternal supplemental folate, choline and DHA on offspring health outcomes
associated with epigenomic changes, and epidemiological analyses of long-term health outcomes associated
with heat stress during pregnancy and lactation. In short, the strength of the U.S. DOHaD Society lies in its
diversity in terms of the research it represents and those researching these areas.

Public health relevance
NARRATIVE Developmental Origins of Health and Disease (DOHaD) is a well-accepted concept that exposures during early life (fetal and newborn periods) influence individual’s health and disease risk across the life span. The major contributing factors include environmental toxicants, nutrition, microbiome, stress, hormones, metabolites, drugs, and alcohol. The US DOHaD Society’s missions are to promote diversity and inclusion in the Society’s leadership, to facilitate collaborative studies on these important factors in order to understand their roles in health and disease, and to bring together clinicians, toxicologists, epidemiologists, nutritionists, physiologists, and basic scientists to develop novel preventive strategies, advocate for sound public policy, and ultimately improve the health of Americans.